Quantitative Team Science (QuanTS) Program

PROJECT SUMMARY
As the demand for data-intensive, interdisciplinary research increases, so does the demand for quantitative
scientists who excel not only at working with data but also at collaborating effectively within research teams
across all fields of medicine. Despite the integral role that quantitative scientists play on these teams, they
typically receive very basic, if any, targeted team science training during their graduate studies or in the
workplace. We propose the creation of the Quantitative Team Science (QuanTS) Program to provide scalable
methods for training and mentoring quantitative scientists who are currently working within the biomedical
research community, to foster the knowledge, attitudes, and behaviors inherent to effective team science.
Relying on our team’s past work, our innovative approach focuses on competencies and skills that are specific
to quantitative team scientists. We will first create a series of online educational modules to train quantitative
team scientists in ten key collaborative skills. These modules, including both didactic training materials and an
accompanying mentor guide, are designed to be asynchronous and self-paced, allowing for a flexible,
accessible, and sustainable modality that can be easily scaled and utilized by a broad range of learners. Next,
we will implement a small-group, synchronous mentorship program for quantitative team scientists to gain
more experiential training and focused mentorship in ten key collaborative skills. In this seven-month program,
participants will benefit from a three-pronged mentorship approach including program mentorship, peer
mentorship, and home institution mentorship. Throughout the development and deployment of the online
educational modules and the focused mentorship program, we will integrate a mixed-methods evaluation
process that examines the facilitators, barriers, and outcomes of the QuanTS Program in practice, including
examining changes for quantitative scientists, their mentors, and their domain collaborators as a result of the
program. This will provide directly actionable information to inform processes for sustaining/expanding the
QuanTS Program and will also provide guidance for future quantitative team science trainings. The
comprehensive QuanTS Program will grow the workforce of highly-skilled quantitative team scientists who can
integrate diverse scientific perspectives into data analyses, communicate results to a range of audiences, and
cultivate positive interpersonal relationships within the biomedical research environment. Quantitative scientists
are integrated within research teams across all disciplines and phases of biomedical research. Improving the
way in which quantitative scientists collaborate with biomedical investigators (e.g., clinicians, bench scientists,
domain experts) to conduct interdisciplinary research not only enhances the efficiency and rigor of data
analyses but also holds the potential to accelerate the translation of research findings into tangible clinical
applications, thereby advancing the frontiers of medical knowledge and patient care.

Public health relevance
PROJECT NARRATIVE The Quantitative Team Science (QuanTS) Program will provide training and mentorship in collaborative skills to equip quantitative scientists to work effectively on research teams across all fields of medicine. To accomplish this goal, we will create online didactic training materials that are broadly accessible to the quantitative science community, facilitate an experiential, small-group mentorship program focused on team science skills for early-career quantitative scientists, and provide guidance and training materials for mentors. We will also integrate novel evaluation processes within the program to examine facilitators, barriers and outcomes of the proposed methods for training and mentoring quantitative team scientists.